CORE--BIOCHEMISTRY

The Biochemistry Core within the Regional Bone Center will be responsible for the performance of biochemical assays related to bone metabolism with the samples collected in Projects 2, 3, 4, and 5. In Project 2, we will attempt to elucidate the cellular mechanism of action in a rat model of ovarian-dysfunction induced osteoporosis. Measurements made in Core B are critical for Project 2 in answering the questions of the alteration in the PTH-vitamin D-Ca axis in the pathogenesis of bone loss. Following temporal changes in bone formation and resorption markers, we can relate the results with the changes found in histomorphometric or bone mass measurements and thus validate the use of such non-invasive techniques. In Project 3, we will examine the changes of streaming potentials in normal animals and those animals with disuse or estrogen deficient osteoporosis with or without the receipt of therapeutic agents. Measurements made in Core B will be used to monitor the differences in turnover parameters and help to estimate the progress of bone loss and the usefulness of the intervention prior to the measurements of streaming potentials. In Project 4, biochemical, histomorphometric, and bone mass determinations in postmenopausal women with primary hyperparathyroidism will be analyzed and compared to postmenopausal women without primary hyperparathyroidism. In addition, estrogen will be tested as a therapeutic agent for primary hyperparathyroidism. Measurements in Core B will pay special attention to the role of vitamin D metabolites and the bone resorption markers, pyridinoline and deoxypyridinoline, so that we can assess the effects of elevated PTH, estrogen or both in postmenopausal women. Finally, in Project 5, a combination of estrogen and PTH will be used as a possible therapeutic regimen to increase bone mass in postmenopausal osteoporotic women. Whereas bone mass and histomorphometric determinations can only be performed between extensive intervals, continuous monitoring of bone formation and resorption markers can be performed in the Core B and evaluated by the investigators as needed. The change in histomorphometric parameters and bone mass will be compared with biochemical parameters to determine the most useful biochemical parameter(s) in predicting net bone gain.